Thrombopoietin Mimetic Peptides for Treatment of Fractures

SUMMARY
Veterans with fractures suffer from injury-associated pain as well as post-operative surgical pain. The
occurrence of a fracture contributes to acute pain and is largely manifested by mechanical, inflammatory, and
neuropathic components. The LEAP study of high-energy lower extremity trauma showed that acute pain, in
the recovery period after severe trauma, is the single largest predictor of long-term chronic pain 5-10 years
after injury. There are 2 main strategies to treat trauma-induced and post-surgical pain: opioids and
nonsteroidal anti-inflammatory drugs (NSAIDs). Neither drug class completely alleviates pain, and both have
negative side effects. Opioids, beyond eliciting cognitive impairment, are commonly associated with tolerance
and addiction. NSAIDs are commonly used in combination with opioids following thoracic/abdominal surgery
but use of this drug class for fracture pain is discouraged in the U.S. due to negative effects on skeletal health
and healing of the injured skeleton. It is unclear which drug class is less destructive to the bone repair process
but prevention of nonunion is paramount in the treatment of fractures as it places additional burden on the
patient and the healthcare system due to prolonged pain and disability. Therefore, identification of therapies
which improve both the bone healing process and diminish the fracture-associated pain is warranted. Our
group has previously shown that the main megakaryocyte (MK) growth factor, thrombopoietin (TPO), can
improve bone healing. In preliminary studies we demonstrate that fracture targeting thrombopoietin mimetic
peptides (TMPs) also markedly improve fracture healing, and that high levels of platelet derived growth factor
(PDGF) are observed at the fracture site with TMP treatment. As both osteoblasts (OBs) and endothelial cells
(ECs) express the receptor for PDGF (PDGFRβ), actions of PDGF on these cells could be responsible for the
improvements in bone healing observed. On the other hand, PDGF expression is also known to increase pain
behaviors, and PDGFRβ is also expressed on sensory neurons. Based on these observations we
hypothesize that short-term administration of TMP will increase PDGF at the fracture site, stimulating OB
and EC activity, leading to accelerated bone healing. Because inhibition of the PDGF-PDGFRβ axis has been
shown to attenuate pain behaviors, we further hypothesize that inhibition of PDGFRβ-signaling subsequent
to the inflammatory phase of fracture healing, at 8-30 days post-surgery, will decrease chronic pain and
inflammation without compromising fracture healing. Three specific aims will address this hypothesis. In Aim
1, we will determine if systemic versus targeted TMP can accelerate post-fracture bone healing and reduce
inflammation and pain behaviors. In Aim 2, we will determine if PDGFRβ signaling in OBs and/or ECs is
required for TMP-stimulated bone healing. In Aim 3, we will determine if inhibiting PDGFRβ-signaling
following TMP treatment reduces chronic pain behavior. Identification of novel inhibitors of chronic pain could
also decrease the use of opioids for pain management of musculoskeletal injuries and serve as an important
step in mitigating the opioid crisis.

Public health relevance
NARRATIVE Chronic pain and disability after bone fracture is common. Approaches to pain management following orthopaedic surgery often include the use of opioids. We have identified a new targeted bone healing agent that may not only improve bone healing but may also decrease the associated pain. The latter could replace the necessity of opioids for pain management and serve as an important step in fighting the current opioid crisis.